Fetal Programming of Human Newborn Energy Homeostasis Brain Networks And Infant Adiposity

PROJECT SUMMARY Not applicable for this revision proposal.

Public health relevance
PROJECT NARRATIVE Not applicable for this revision proposal.